Zambia AIDS Malignancies Diagnosis and Pathogenesis Program Supplement

ABSTRACT
The establishment of the Zambia AIDS Malignancies Diagnosis and Pathogenesis Program (ZAMDAPP) will
support the U.S.-Zambia collaborations necessary to develop a robust cancer research infrastructure at
Zambia’s Cancer Diseases Hospital (CDH) and University Teaching Hospital (UTH), with an initial focus on
Kaposi’s sarcoma (KS) and ocular surface squamous neoplasia (OSSN) – two of the most common occurring
HIV/AIDS-associated malignancies in the country. ZAMDAPP will, for the first time, provide a mechanism by
which R01-style research projects led by Zambian scientists trained through the Fogarty International AIDS
International Research and Training Program (AITRP, D43TW001429) and AIDS Malignancies Training and
Research Program (AMTRP, D43TW010354) may be conducted in three areas critical to cancer research –
virology, biostatistics and epidemiology, and cancer diagnostics. The Zambian personnel leading the research
projects will benefit from mentoring by U.S. partners and support by a number of research core facilities.
ZAMDAPP will leverage strengths in clinical care and treatment at CDH and UTH; strengths in molecular viral
oncology research and cancer genomics at the University of Nebraska-Lincoln; and strengths in pathology,
epidemiology, and biostatistics at the University of Nebraska Medical Center, while extending the work that has
been accomplished through AITRP and AMTRP, which provide support for trainees to pursue advanced
degrees. In addition to providing research funding, ZAMDAPP will provide diverse training activities in the
United States and Zambia to engage the next generation of Zambian cancer researchers, increase local
expertise, and enhance the transfer of technology. The partnership will lead to exchanges that build the
technical and personnel infrastructure necessary to perform the high-quality and sustainable cancer research
desperately needed in Zambia. Three specific aims will be accomplished: 1) develop the cancer research
infrastructure at UTH and CDH through the establishment and enhancement two research core facilities; 2)
provide an opportunity for former Fogarty trained fellows to lead hypothesis-driven research projects in the two
more prevalent AIDS-associated malignancies, KS and OSSN, with the support of the U.S. partners and the
core facilities; and 3) develop a pipeline of next generation Zambian cancer researchers through a) in-country
workshops, b) pilot project funding, and c) short-term U.S. technical training. ZAMDAPP will build on
successful ongoing Fogarty and National Cancer Institute training programs led by the PI and the leadership
team in sub-Saharan Africa; implement a cross-disciplinary research and training program with different
training tracks and in-country research projects that pair Zambian and U.S. researchers along with
opportunities to conduct hypothesis-driven research projects; and be Zambian driven and benefit from broad
local support. Thus, there is strong potential for ZAMDAPP to success in reaching its goal.

Public health relevance
PROJECT DESCRIPTION The proposed consortium has a strong potential to improve health outcomes in Zambia by providing the training, mentoring, and infrastructure to develop a strong cancer research program with a focus on Kaposi’s sarcoma and ocular surface squamous neoplasia at the Cancer Disease Hospital.